The role of geometric structure in avoidance of oxygen rebound to enable aliphatic halogenation and oxacyclization by non-heme Fe(IV)-oxo (ferryl) complexes

Project Summary/Abstract
Iron(II)- and 2-(oxo)glutarate-dependent (Fe/2OG) oxygenases catalyze hydroxylation, halogenation,
cyclization, dehydrogenation, and stereoinversion of aliphatic carbon centers, C–H-bond-activation reactions
that collectively represent a holy grail of synthetic chemistry. Biosynthetic pathways to important natural-
product drugs are replete with these enzymes, and the pharmaceutical industry is beginning to leverage
evolved versions of Fe/2OG oxygenases as biocatalysts for "green" processes to their synthetic drugs. Recent
studies of Fe/2OG hydroxylases, halogenases and cyclases by the Penn State group show that the disposition
of the substrate relative to the common iron(IV)-oxo (ferryl) and iron(III)-hydroxo/substrate-radical
intermediates may be crucial for control of reaction outcome. On the basis of data available so far, we
hypothesize that the structural rearrangement of the metallocofactor rather than the substrate positioning is the
primary factor directing regioselectivity. Therefore, in this work, we will perform spectroscopic characterization
of faithful reactive-state analogs to gain first-hand insight as to how the individual enzymes adjust the structure
of the active complex and to uncover common modes that direct reactivities in the superfamily of Fe/2OG
oxygenases. In this project, we will innovate and deploy a suite of novel intermediate mimics and spectroscopic
probes/methodologies to resolve the geometries of the key intermediate states in the pharmaceutically relevant
subclasses of Fe/2OG enzymes. Our elucidation of how the cofactor structures and relative dispositions of the
substrates dictate the divergent outcomes will inform efforts to discover novel members of this superfamily and
assign their phenotypes. Ultimately, information obtained in this project will be instrumental in developing new
biocatalysts for drug synthesis.

Public health relevance
Project Narrative Non-heme-iron and 2-oxo-glutarate-dependent enzymes perform an incredible array of oxidative transformations in biosynthetic pathways of medicinal natural products. This project seeks to understand which structural factors allow the metallocofactor in these enzymes to perform various reactions. Uncovering this knowledge will unlock the opportunities for bioengineering these enzymes for novel drug synthesis and develop innovative bio-inspired chemical processes.